CORE--RESOURCES

The core resources include the computer hardware and support personnel required to supply the computational needs of the component projects. The core will also provide the administrative personnel for the visiting scientist program for the program project and for the organization of meetings.